Identifying a novel player in skeletal muscle performance and metabolism

Project Abstract
Skeletal muscle (SkM) function and strength, and intrinsic muscle quality are closely linked to the pathogenesis
and pathophysiology of metabolic disease. However, the regulatory molecular mechanisms in SkM performance
remain elusive. The current proposal will focus on identifying novel molecular pathways regulating muscle
function and insulin signaling via the muscle-specific role of Fat Specific Protein 27 (FSP27). While the adipocyte
actions of FSP27 have been well-recognized in the metabolic field, we unexpectedly discovered high FSP27 protein
expression in SkM. Our preliminary data in humans identified a positive correlation of SkM FSP27 expression with
indices of muscle performance such as aerobic capacity, muscle strength, and responsivity to exercise training. Also,
our study in whole-body Fsp27-/- mice displayed severely impaired muscle endurance, muscle strength, and loss of
fat in the SkM. Intramyocellular fat is a crucial source to meet the energy demand in the SkM for its function.
Therefore, we hypothesized that FSP27 plays a major role in muscle performance and insulin sensitivity primarily via
its role in regulating fat handling in the SkM. As a first step in understanding the clinical relevance of FSP27 in
SkM insulin signaling and muscle function, we have generated an innovative gain-of-function transgenic mouse
model expressing the human-FSP27 transgene, (M-FSP27tg), specifically in SkM without altering the expression
of endogenous mouse Fsp27. Also, we have generated a loss-of-function muscle model through muscle-specific
ablation of FSP27 (M-Fsp27-/-). Our preliminary studies in these mouse models are in-line with our hypothesis and
suggest a critical role of SkM-specific FSP27 in muscle performance. We will utilize a three-pronged approach to
identify the physiological and molecular mechanism of FSP27-mediated SkM function. In Aim 1, we will study the
physiological action of FSP27 in SkM performance, and its role in protection against obesity-induced whole-body
insulin resistance. In Aim 2, we will test our hypothesis that FSP27 handles intramyocellular fat fuel via its action
on the motor activity of the cytoskeletal proteins along the FSP27-Rab18-p150-Dyenin axis in the SkM. In aim
3, we will test our hypothesis that in addition to its effect on cytoskeleton motor activity, FSP27 regulates exercise
endurance and insulin sensitivity via the glucagon-like peptide 1 receptor (GLP1R)-AMPK pathway. A strength
of this proposal is an interdisciplinary collaboration formed between Dr. Puri (expert in basic and translational
research in lipid metabolism and signaling), Dr. Consitt (expert in SkM metabolism), Dr. Baumann (expert in SkM
physiology), and Dr. Lee (expert in tissue insulin signaling), which will utilize their complementary expertise and
build upon their collaborative work in this project. Successful completion of the proposed studies will identify a
novel regulatory player in SkM performance and muscle biology.

Public health relevance
Project Narrative Skeletal muscle plays a critical role in glycemic control and metabolic homeostasis and is the predominant site of glucose disposal under insulin-stimulated conditions. Therefore, skeletal muscle function is a very important fundamental phenomenon in human health and disease. This project will use physiological and molecular approaches to identify new molecular pathways playing a role in muscle performance and metabolism.